Caregiver SOS: An Intervention for Employed Caregivers

Background: Research has shown that unpaid, informal caregivers (CGs), such as family and friends, who
are also employed may be at significant risk of experiencing burden and stress. A recent national survey found
that approximately 60% of employed CGs had significant problems balancing work and caregiving. Stress not
only increases the CG’s risk of illness and diminishes their quality of life; it also impacts the CG’s ability to
provide care for the care recipient (CR) and overall relationship quality. Moreover, while work frequently adds
to the CG’s stress, relinquishing work can create new stress for both the CG and CR, particularly when it
involves losses in resources such as income, benefits, social contacts and/or respite from caregiving duties.
Significance/Impact: Approximately 5.5 million Veterans rely on CGs to help them with their daily care. CGs
often cope with stress and strain from CG/work roles. This may be particularly true of CGs of Veterans coping
with behavioral health issues related to conditions such as depression, posttraumatic stress disorder (PTSD),
anxiety, and traumatic brain injury (TBI). Programs that specifically address caregiving-work role stress may
be especially effective in improving CGs’ wellbeing and work/financial stability and the quality of Veterans’
care. Given this project’s focus, it is responsive to multiple ORD and HSR&D priority areas, including long-
term care/aging, access to care, mental health/PTSD, and health equity, expanded Veteran/CG access to high
quality clinical trials, and legislative priorities such as the MISSION Act, which emphasizes research on new
models that support and benefit both Veterans and CGs and maximize the ability of Veterans to age in place.
Innovation: The evidence for CG stress interventions is limited mainly to studies of psychoeducational and
support programs, many of which are targeted to specific groups of CGs (e.g., CGs of individuals with
dementia). Few studies address CGs in the context of their work and CG roles, and even fewer focus on CGs
of Veterans with behavioral health conditions, who often provide care to CRs with complex symptom profiles.
To our knowledge, no program specifically targets work functioning and productivity among employed CGs.
Specific Aims: The aims of this study are to, 1) determine the extent to which, relative to usual care, a novel
intervention providing evidence-based, telephonic CG/work stress self-management counseling is related to
changes in CG psychological distress and ability to function effectively in work and CG roles, and 2) evaluate
whether participation in the intervention is related to CGs’ overall wellbeing and CRs’ health care utilization.
Methodology: We will conduct a randomized controlled trial and compare pre/post changes among 300 CGs
allocated to the Caregiver SOS (for Self-Management of Stress) program or usual care. CGs who, 1) care for
Veterans diagnosed with depression, anxiety, PTSD, and/or TBI and, 2) screen positive for clinically significant
distress and CG/work role difficulty will be recruited to participate from two VA Medical Centers and their
affiliated outpatient clinics. A novel intervention, Caregiver SOS includes 6, 1-hour telephonic sessions with a
care manager. Usual care will consist of 1 telephonic session with a care manager. Primary and secondary
outcomes will be pre-post change in CG distress and work functioning, respectively. Additional CG and CR
outcomes (i.e., physical mental and interpersonal functioning) also will be measured and analyzed. CRs’ VA
health utilization data will be extracted from clinical patient records and non-VA health utilization data will be
collected via CG self-report. Intent to treat analysis using mixed effects models will be used to test the study
hypotheses. We anticipate that CGs in the intervention arm will show significantly greater improvements in
outcomes compared to those in usual care.
Next Steps/Implementation: We will work with our local and national partners (e.g., Caregiver Support
Program; Office of Mental Health and Suicide Prevention) to evaluate findings and devise a strategy for
ultimately testing effectiveness and implementation of the intervention both locally and across multiple sites.

Public health relevance
Unpaid informal caregivers (CGs), such as family and friends, who are also employed may be at significant risk of experiencing burden and stress. This may be especially true for CGs who provide care to care recipients coping with behavioral health issues associated with conditions like depression, anxiety, post-traumatic stress disorder and traumatic brain injury. Stress not only increases the CG’s risk of workplace difficulties, illness, and poor quality of life, but also impacts the CG’s ability to provide care for the care recipient. The primary aim of this randomized study is to examine the impact of a novel intervention, Caregiver SOS (Self-Management of Stress), on CG distress and work performance and productivity. Caregiver SOS is delivered by phone and offers evidence-based, work and CG role performance-focused self-management counseling to employed CGs. Study findings will ultimately shed light on whether a program that specifically addresses caregiving- work balance is effective in improving CGs’ wellbeing and work functioning and the quality of Veterans’ care.